Trainging Program in Hearing and Balance

Summary/Abstract
This is an application for renewal of T32 DC000023, “Research Training in Hearing and Balance” to the
Center for Hearing and Balance (CHB) at Johns Hopkins University in Baltimore, Maryland. Pre-doctoral
(4) and postdoctoral (4) training slots are requested. The interdepartmental Center for Hearing and
Balance brings together expertise from across the Johns Hopkins University to inspire and promote
research into basic mechanisms of hearing and balance, pathogenesis and innovative therapeutic
strategies. While training opportunities are widespread and deep within each of the home
departments, the mission of the Center is to provide a common knowledge base and technical expertise
for trainees to advance their hearing and balance-related research goals. Research progress at all levels
from molecular genetic to public health depends on well-trained investigators who are knowledgeable
about hearing and balance from peripheral mechanisms to behavioral consequences. To accomplish
that goal, auditory and vestibular studies employ integrated knowledge from engineering, biology and
behavior. The training faculty of this T32 spans that wide range of knowledge and expertise and so
uniquely prepares pre- and postdoctoral trainees at Hopkins for this field. The inclusion of a strong
cohort of clinician-scientists ensures that trainees will understand the relationship of their research
training to health and disease.

Public health relevance
Project Narrative Research training in hearing and balance requires a wide range of experimental and theoretical knowledge. This training program brings together experts from molecular genetics to population health to produce the next generation of scientists addressing these all-important senses. The gradual decrement of hearing and balance in our increasingly aged population makes this effort especially meaningful.